Open, Extensible, Standardized, and Customizable Computational Tools for Optical Brain Mapping

PROJECT SUMMARY/ABSTRACT
We propose to broadly disseminate and extend intuitive, powerful cloud-based resources for optical brain
mapping that facilitate efficient, accurate, and standardized processing that will harmonize the emerging set of
optical measurement strategies within the growing ecosystem of network level analyses used throughout the
greater brain mapping community. The neuroimaging community faces numerous challenges in data collection,
preprocessing, estimation of brain connectivity, and analyses of relationships between brain connectivity and
behavior. An ever-expanding community of researchers are employing optical methods based on functional near
infrared spectroscopy (fNIRS) in order to infer pathophysiological state of tissue, such as inflammation and
metabolism for detection/characterization of disease or cerebral hemodynamics for understanding human brain
health, development, and aging. Recent developments of high-density diffuse optical tomography (HD-DOT), a
silent, flexible, and scalable technology have demonstrated dramatically improved anatomical specificity and
image quality over traditional fNIRS. Further, recent developments in wearable HD-DOT, even using frequency
domain and time resolved strategies, open the door to unconstrained mapping of naturalistic human brain
function with superior image quality than previously possible. Given the growing worldwide adoption of fNIRS
and HD-DOT methods and further developments of next-generation optical brain mapping methods via the
BRAIN Initiative, there is an urgent and present need for standardized, accessible and flexible tools that directly
support workflows from optical tissue parameter recovery to functional brain mapping to relating variance in brain
function to behavior and outcome. To address these needs, our teams have developed and validated
computational tools including NIRFAST, NeuroDOT, and Network Level Analyses (NLA), for tissue parameter
recovery, optical brain mapping, and model-based connectome-wide association studies of brain function and
behavior, respectively. While these tools each support growing user communities, the tools are based in Matlab,
which significantly limits accessibility and adoption. Additionally, much of these analyses are computationally
intensive and expensive, limiting full use to institution-based, server-level resources. Further, extant widely
available software packages for fNIRS are limited in scope and do not support the full set of pipelines for end-
to-end analyses that together NIRFAST, NeuroDOT, and NLA provide. We therefore propose herein to utilize
funding from RFA-NS-23-026 to address this unmet need for data resources with (1) greater dissemination and
training for our tools, (2) cloud deployment of our software to increase scale and accessibility, while easing the
computational burden for the user, and (3) expanded utility of these powerful, flexible tools to meet the evolving
needs of users at the forefront of optical imaging technology development. This proposal executes BRAIN
Initiative goal 7 that seeks to integrate new technological and conceptual approaches to discover how dynamic
patterns of neural activity are transformed into cognition, emotion, perception, and action in health and disease.

Public health relevance
PROJECT NARRATIVE The neuroimaging community faces numerous challenges in data collection, preprocessing, estimation of brain connectivity, and analyses of relationships between brain connectivity and behavior. An ever-expanding community of researchers are employing optical methods based on functional near infrared spectroscopy and diffuse optical tomography in order to infer pathophysiological state of tissue, such as inflammation and metabolism for detection/characterization of disease or cerebral hemodynamics for understanding human brain health, development, and aging. We propose to broadly disseminate and extend intuitive, validated, powerful cloud-based resources for optical brain mapping that facilitate efficient, accurate, and standardized processing that will harmonize the emerging set of optical measurement strategies within the growing ecosystem of network level analyses used throughout the greater brain mapping community.